Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories

FDA (U18) GRANT PROPOSAL FOR FOA # RFA-FD-19-018 Abstract Summary This grant proposal from the Ohio Department of Agriculture is in response to Funding Opportunity Announcement (FOA) # RFA-FD-19-018 from the Food and Drug Administration’s (FDA) Office of Regulatory Affairs (ORA) and Center for Food Safety and Applied Nutrition (CFSAN). Its purpose is to advance our nation’s food safety system through enhancement of state food laboratory activities. The goal is a create a National Integrated Food Safety System and support the FDA Food Safety Modernization Act. This application covers Competition A and B. The ADDL is also poised to address new developments in emerging regulatory sciences as well as urgent or novel areas for potential research. We are confident that we can meet the objectives of this project and look forward to the opportunity to work with the FDA. The Quality Manual (ISO 17025 accredited) and management practices provide a high level of confidence in the reliability of results for all existing programs. The laboratory has a proven ability to perform large numbers of chemical and microbiological analyses with excellent turn- around-time for reporting results. The ODA-CPL has a history of active participation in national food safety surveillance programs and in the investigation of significant chemical and microbiological emergencies in the United States. The ODA-CPL laboratories have an excellent inventory of relevant instruments and equipment that could also be utilized during food emergency conditions or in the case of large-scale testing needs.

Public health relevance
FDA (U18) GRANT PROPOSAL FOR FOA # RFA-FD-19-018 Project Narrative The food safety system has continually encountered risks and emergencies of significant national veterinary and human health. The FDA Food Safety Modernization Act provides FDA with tools to better protect public health by strengthening the food safety system. Functioning as an ISO-17025 accredited laboratory and utilizing whole genome sequencing are efficient tools that aid FDA in developing a stronger international rapid surveillance system for pathogen traceback through the GenomeTrakr network.